Investigating the Role of GSK3A in Cohesin Dynamics and Gene Regulation

PROJECT SUMMARY
Cohesinopathies are multisystemic developmental disorders characterized by limb abnormalities, intellectual
disability, and heart defects. They are caused by mutations in the structural or regulatory components of the
cohesin complex. Cohesin is essential for interphase genome organization by forming chromatin conformations
that position distal genomic regions into spatial proximity. Cohesin-mediated structures are implicated in gene
regulation, DNA repair, and somatic recombination. Indeed, cells from individuals with Cornelia de Lange
Syndrome (CdLS), the most well-characterized cohesinopathy, exhibit transcriptional dysregulation, suggesting
that impaired interphase cohesin function may be responsible for patient phenotypes. The majority of CdLS
patients carry a loss-of-function mutation in the cohesin activator NIPBL. Therefore, balancing cohesin activity
on chromatin by inhibiting a negative cohesin regulator may provide therapeutic benefits for CdLS patients.
However, the development of targeted therapies for CdLS has been hindered by the lack of characterized
cohesin regulators during interphase. To address this, our lab performed a high-throughput imaging screen of
the human druggable genome, which identified Glycogen synthase kinase-3 alpha (GSK3A) as a negative
regulator of cohesin. My preliminary work has identified three phosphorylated residues on the cohesin regulator
PDS5A that depend on GSK3 activity, albeit how GSK3A regulates cohesin is still unclear. The goal of this
proposal is to elucidate the mechanism by which GSK3A negatively regulates cohesin and the extent to
which GSK3A inhibition can rescue expression of cohesin-sensitive genes.
In Aim 1, I will determine the role of the GSK3-dependent phosphorylated residues in PDS5A on cohesin
regulation. To this end, I will create transgenic cell lines harboring wild-type, phosphomimetic, or
phosphodefective PDS5A mutants at the GSK3-dependent sites. Using these cell lines, I will assay how
preventing or constitutively mimicking PDS5A phosphorylation affects PDS5A loading onto chromatin and
interactions with cohesin subunits. Furthermore, I will determine how the phosphomutants affect cohesin
localization and chromatin folding. In Aim 2, I will identify the role of GSK3A in transcriptional regulation of
cohesin-sensitive genes. I will first perform PRO-seq to measure changes in nascent expression of cohesin-
sensitive genes upon GSK3A inhibition. Then, I will determine the degree to which GSK3A inhibition is able to
rescue expression of genes when NIPBL is knocked down. As a functional readout of transcriptional rescue by
GSK3A inhibition, I will assess whether GSK3A inhibition is able to restore cell cycle progression, which is
impaired in NIPBL-deficient cells.
Completion of these aims will provide mechanistic insights into regulation of cohesin by GSK3A and establish
the foundations for studying GSK3A or other negative cohesin regulators as therapeutic targets for CdLS.

Public health relevance
PROJECT NARRATIVE The cohesin complex plays an evolutionarily conserved role in spatially organizing the genome and regulating gene expression during interphase. Mutations in cohesin subunits or regulators cause a group of developmental disorders termed cohesinopathies; however, there are no targeted therapies for cohesinopathies due to the lack of characterized cohesin regulators during interphase. Elucidating the mechanisms by which the recently identified cohesin regulator GSK3A modulates cohesin activity is crucial for exploring its potential as a therapeutic target for cohesinopathies.